Decreasing Sedative Requirements for Peripheral Vascular Interventions using Preoperative Guided Meditation

Project Summary/Abstract:
Patient anxiety is widely prevalent and can be compounded for patients undergoing procedures
under procedural sedation and analgesia (PSA), in contrast to general anesthesia, as they remain
awake and continuously aware of perioperative activity. The treatment of perioperative anxiety has
traditionally revolved around the administration of anxiolytics and analgesics, most commonly in the
form of short-acting opioids and benzodiazepines. However, these medications not only have short
term side effects including respiratory depression and possible apnea but can also in some cases result
in addiction and long-term dependence.
We propose a novel intervention: a perioperative, surgery-specific guided meditation program to
decrease patient anxiety. We believe that such a meditation program is an optimal means of
decreasing anxiety in vascular surgery patients as it is a non-pharmacologic intervention that has
proven to be effective in decreasing perioperative pain and anxiety for patients undergoing general
anesthesia in the specialties of cardiac and spine surgery. Additionally, guided meditation techniques
such as the body-scan technique and breath-focused meditation are synergistic with what patients are
requested to do intraoperatively, namely keeping their legs immobile and intermittently holding their
breath. From a feasibility standpoint, we are also encouraged that meditation has previously been
successfully implemented in the perioperative arena, though prior meditation interventions have not
been for patients under conscious sedation (as opposed to general anesthesia) nor have they
incorporated surgery-specific information as they had used generic pre-existing techniques.
In order to create the aforementioned meditation program in a scientifically rigorous manner, we
will assemble a panel of stakeholders to include meditation experts, patients and vascular surgeons.
Via the Delphi method, this panel will generate key tenants of a meditation program specific to patients
undergoing peripheral arterial endovascular interventions, according to which the meditation program
will subsequently be created. A pilot feasibility study will then be performed, with a recruitment period
to last a year, and outcomes including patient perioperative anxiety will be analyzed.
When completed, this study will provide data regarding the feasibility and impact of a surgery-
specific guided meditation program on patients undergoing peripheral arterial endovascular
interventions. We also expect to collect adequate preliminary data so as to power a randomized control
study. Finally, we envision that our study will draw attention to the importance of patient-centered
research and stimulate further investigations into addressing perioperative patient anxiety.

Public health relevance
Project Narrative: Perioperative anxiety results in increased anesthetic requirements in the form of short-acting benzodiazepines and opioids. These pharmacologics not only have short term side effects including respiratory depression and possible apnea but can also in some cases result in addiction and long-term dependence. We propose to design, create and test a novel perioperative, surgery-specific guided meditation program with the aim of decreasing analgesic and anxiolytic requirements in patients undergoing peripheral vascular interventions.